Shared Resource Management

SHARED RESOURCE MANAGEMENT (SRM)
PROJECT SUMMARY/ABSTRACT
Shared Resource Management (SRM) is the administrative management unit for eight Shared Resources (SRs)
that offer scientific services to CINJ members throughout the Rutgers University/Princeton University consortium.
The mission of SRM is to support the scientific development, administrative governance, and financial
accountability of CINJ’s SRs. We fulfill our mission by promoting cost-effective services that support the five
Research Programs, align with CINJ’s strategic plan, and support member needs. Our SRs offer cutting edge
instrumentation, centralized intellectual and technical resources, and advanced technical support that drive
innovative cancer research. SRM is led by the Associate Director for Shared Resources (ADSR), Adam Berger,
MD, who is supported by Ioannis Stasinopoulos, PhD, Assistant Director for SRs. Under their leadership CINJ
re-configured each of the eight SR advisory committees (SRACs) to function as the primary venue of internal
planning and evaluation for the respective SRs; emphasized satisfaction surveys with tracking of action items
and discussion of satisfaction survey comments in each annual SRAC meeting; deployed scientific service
development surveys that are discussed with the respective SRAC and CINJ’s Research Leadership Council
(RLC); improved chargeback collection and communicated chargeback expectations to SRs; implemented iLab
Solutions billing and scheduling; and employed a publication tracking process. SRM reports on SR scientific
achievements and opportunities and on member feedback to the RLC as needed. SRM reviews finances,
staffing, and business planning with the AD for Administration and Planning quarterly and as needed. Informed
by the scientific recommendations made by the RLC and the financial planning by the AD for Administration and
Planning, the ADSR recommends actions to the Center Director who maintains authority over all SR
management decisions. SRM supports the CINJ mission with the following specific aims: 1) Provide centralized
cutting-edge scientific services, technologies, consultation, and expertise to meet strategic plan objectives and
member needs; 2) Provide operational oversight, cost-effectiveness, accessibility, business planning, and
customer satisfaction and feedback that expand scientific excellence, and 3) Promote training and outreach
activities that expand the member base and strengthen productivity and collaboration at CINJ. In order to
continue to effectively support these aims and the CINJ Strategic Plan for growth and expansion of services,
SRM will hire a programmer and data analyst to automate the distribution of satisfaction surveys following the
completion of each experiment and fully automate utilization capture and analysis. SRM will support SR
modernization initiatives across the translational continuum by supporting the developing Organoid Development
SR and synergizing the genomics, computational science, and bioinformatics areas to take advantage of the
deployment of Epic® and the considerable strength in basic science genomics research at the Lewis-Sigler
Institute for Integrative Genomics at Princeton University.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)